State of Nevada Manufactured Regulatory Program Standards Maintenance 2024

State of Nevada Manufactured Regulatory Program Standards Maintenance 2024
RFA-FD-23-027
Project Summary and Abstract
This project charts the next phase of the program standards allowing the state of Nevada to continue
program improvements that began in 2011. Since 2021 the Nevada Division of Public and Behavioral
Health, Environmental Health Section is in full compliance with the program standards. Our primary
goals are to continue to expand the contract work with the U.S. Food and Drug Administration. For
2023, we have taken on Dietary Supplements for contract work and plan to continue developing our
advanced inspection practices. The State of Nevada is also working toward taking over manufacturing
work in the local health authority regions to bring it under state control.

Public health relevance
State of Nevada Manufactured Regulatory Program Standards Maintenance 2024 RFA-FD-23-027 Project Narrative, Manufactured Food Regulatory Program Standards. This submission will continue to improve the MFRPS program. This form covers the overall project, a core project for Standards 1-10 and support for the Nevada Food Safety Task Force.